Immunization strategies to elicit broadly neutralizing antibodies against HCV

PROJECT SUMMARY
Hepatitis C virus (HCV) infects over 70 million people worldwide and is a leading cause of chronic liver cirrhosis
and liver cancer. Despite the success of direct-acting antivirals, control of the HCV epidemic remains challenging
due to difficulties in early virus detection, the high cost of therapy, and possible reinfection after the successful
treatment. An effective prophylactic vaccine would help to control the epidemic, but the enormous genetic
diversity of the HCV hampers its development. Despite the high variability of the virus, 30% of HCV-infected
individuals clear the viral infection by developing broadly neutralizing antibodies (bNAbs) that bind to conserved
neutralizing epitopes of HCV glycoprotein E2. By stimulating the development of bNAbs by vaccination, the HCV
epidemic might be stopped.
We recently identified several E2 proteins from different HCV isolates that bind to germline precursors of human
bNAbs, raising the possibility of vaccine development using these variants. In this proposal, we aim to use
naturally-occurring E2 proteins to design immunogens that will elicit HCV-specific bNAbs in animal
models. To accomplish this goal, E2 protein or virus-like particle-based immunogens will be tested in wild-type
mice and non-human primates. Next, the structures of HCV-specific antibodies induced by immunization will be
determined. For this, we will sort and sequence epitope-specific B cells from vaccinated animals and express
antibodies from these sequences. Then, we will determine the structures of HCV-specific bNAbs alone or in
complex with immunogens to elucidate the determinants of broad neutralization of HCV by vaccine-induced
antibodies. The detailed analysis of the elicited antibody response will facilitate the optimization of immunogens
by enhancing their specificity and selectivity. Together, the results of these aims will lead to the identification and
characterization of novel vaccine candidates that elicit HCV-specific bNAbs, facilitating the development of an
effective HCV vaccine.
The mentoring phase of this proposal will take place in Dr. Pamela Bjorkman's laboratory at Caltech. Since there
are several critical areas of the proposed project that require additional training, Dr. Andrew Flyak has assembled
a mentorship committee comprising experts in structural biology (Dr. Pamela Bjorkman), B cell immunology (Dr.
Michel Nussenzweig), and HCV biology (Dr. Justin Bailey). By using an interdisciplinary approach developed
throughout this project and support from the mentoring committee, Dr. Flyak will begin the independent phase
of this award, answering fundamental questions that hinder the development of effective vaccines against HCV,
or other rapidly mutating viruses.
!

Public health relevance
PROJECT NARRATIVE Hepatitis C virus (HCV) is a significant public health problem; more than 70 million people are infected with HCV worldwide, and new infections are on the rise. A prophylactic vaccine that elicits high levels of broad and potent antibodies that neutralize HCV can stop the epidemic. Building upon our discovery of naturally-occurring HCV glycoproteins that bind to germline precursors of potent antibodies, we propose to develop and test immunization strategies that will elicit effective HCV-specific antibodies in animal models, which is highly relevant for the development of an effective HCV vaccine.